HARMONIZATION OF SOLUBLE TRANSFERIN RECEPTOR (sTfR) MEASUREMENTS

IAA with the Center for Disease Control and Prevention, CDC, intends to harmonize assay for soluble transferrin receptor, an important indictor to assess the global burden of iron deficiency in children and women of childbearing age. Specific Aims: The interagency agreement with the centers for disease control and prevention (CDC) is intended to conduct activities that will harmonize assays measuring soluble transferrin receptor (STTR), an important indicator to assess the global burden of iron deficiency in children and women of childbearing age. The goal of the harmonization process is to generate comparable date across multiple laboratories using currently available methodologies for measuring sTTR.